Role of Prp protease in the S. pneumoniae ribosome

PROJECT SUMMARY
The Streptococcus genus contains many human pathogens of medical significance. S. pneumoniae is
one of the most important human respiratory pathogens worldwide, and the increased incidence of
multidrug resistance in streptococci is a significant public health concern. Unfortunately, antibiotic
discovery and development has slowed down in recent years, and there is an urgent need for novel
antibiotics against streptococci and other pathogens.
The eubacterial ribosome is an essential organelle, and a target for numerous antibiotics. The
ribosome consists of three RNAs and 56 proteins. One of these proteins, L27, product of the rpmA
gene, is a component of the ribosomal large subunit that does not have an equivalent in eukaryotes
and archaea. In Firmicutes and related bacteria, L27 has an additional 9–12 amino acid N-terminal
extension compared to their counterparts in Gram-negative bacteria like Escherichia coli. We previously
described a novel cysteine protease, named Prp, that cleaves the N-terminal extension of L27, and
showed that this cleavage step was essential for cell viability in Staphylococcus aureus. Here, we show
that, in S. pneumoniae, L27 cleavage by Prp plays a role in ribosome activation.
The overall objective of this exploratory/developmental project is to understand the roles of Prp and
L27 cleavage in S. pneumoniae. Why do S. pneumoniae, S. aureus and related bacteria employ this
additional Prp-mediated L27 cleavage step? Our hypothesis is that cleavage of L27 by Prp serves as a
checkpoint required for full activation of the ribosome and may be associated with dormancy,
persistence and survival under certain conditions. In this project, we will explore the role of Prp and L27
cleavage using a combination of genetics, functional assays, quantitative mass spectrometry and cryo-
electron microscopy. Our specific aims are:
Aim 1: Define the role of Prp and L27 cleavage in ribosome function;
Aim 2: Examine the structural consequences of L27 cleavage.
Our project addresses a gap in knowledge about streptococcal ribosomal structure, assembly and
regulation and targets a hitherto undescribed step in ribosomal assembly—processing of ribosomal
protein L27 by the Prp protease—that appears to be unique to Firmicutes and related bacteria. The role
of L27 in translation is controversial and the role of Prp in ribosomal assembly and function is still
unknown. A better understanding of these processes may lead to more effective therapeutics against
S. pneumoniae and other Gram-positive pathogens that target these mechanisms.

Public health relevance
PUBLIC HEALTH RELEVANCE: Streptococcus pneumoniae is an important human pathogen, and the increased incidence of antibiotic resistance is a significant public health concern. The ribosome is a central organelle in all bacteria and a key target for antibiotics. This project addresses a previously undescribed processing step in the streptococcal ribosome that may play a role in antibiotic resistance and survival under stress conditions, and may lead to the development of novel therapeutic approaches that target this step.